Biostatistics and Data Science Core

SUMMARY/ABSTRACT
The Boston OAIC programs require diverse expertise in experimental design, biostatistics, and data science to
enable successful implementation of rigorous and reproducible research in diverse experimental settings and
populations. To address these needs, we here propose the continuation and some expansion of the Boston
OAIC’s productive and successful Biostatistical Design and Analysis Core. In keeping with the Core’s
complementary foci in statistical methodology and in contemporary analytics, and research software
development, this resource has been renamed the Biostatistics and Data Science Core (BDSC).
The overall goals of the BDSC are to provide biostatistical and data management support to OAIC projects;
collaborate with and provide consultation to OAIC investigators; to provide mentorship and training to
Research Education Component (REC) and Pilot and Exploratory Science Core (PESC) awardees; and to
conduct novel statistics and data science research.
The BDSC’s Specific Aims are:
Aim 1. To collaborate with OAIC investigators and trainees by providing biostatistical and data management
support to OAIC projects
Aim 2. To provide rigorous training in research design and data analysis for REC and PESC awardees, and
Aim 3. To develop and disseminate novel quantitative methods and data science and bioinformatics tools
aligned with the OAIC projects and priorities
Aim 1 builds upon the highly successful collaborations between the BDSC's faculty and the OAIC investigators,
reflected in more than 150 publications in the prior cycles. Aim 2 builds upon and extends our existing
biostatistical and data science curriculum, developed during the current cycle which is undergoing continuous
revision and improvement, and which is specifically tailored to provide quantitative science education both to
quantitative scientists and to allied clinical researchers in aging. Aim 3 extends our current efforts both in the
development of novel statistical methods in survival analysis, pragmatic clinical trials, longevity, and statistical
genetics; and in the development of novel software, reproducibility, and informatics tools now in extensive use
in the biomedical and Boston OAIC communities.
Together these aims will enable the BDSC to cost-effectively support the OAIC's research and training
initiatives. The productivity of prior cycles attests to the impact of the proposed Core on the OAIC's overall
success and underscores the potential value of its continuation to the Boston OAIC's mission.